High Speed Mapping of Mechanical Properties of Tissues

Project Summary / Abstract
The immune system is a compelling foundation for precise, potent, and persistent therapies targeting an
ever-increasing range of diseases. Adoptive Cellular Therapy based on T cells as a “living drug”, often in
combination with Chimeric Antigen Receptor technologies, now provides long-lasting treatment of multiple
hematological cancers. Bringing the success of this approach to solid tumors remains a challenge with high
reward but significant barriers. Of these, the mechanical resistance of the tumor microenvironment is emerging
as a provocative, intriguing, and ultimately actionable mechanism contributing to the immunosuppression seen
in solid tumors. However, the scanning probe methods currently used to map the mechanical properties of
tissues limits effective testing and understanding of this phenomenon. To address these technical challenges,
we introduce a magnetics-based method for mapping tissue stiffness and viscosity that promises greater
speed than atomic force microscopy, the current gold standard. The devices, control systems, and protocols
needed for this approach will be developed in Specific Aim 1 and validated using well-characterized model
systems. This platform will then be used on tissue samples in Specific Aim 2, advancing two strategic
applications of these slices. Successful completion of this developmental / exploratory study is a key proof-of-
principle of our mapping approach, which will be subsequently applied to reveal the impact of tumor
microenvironment mechanics on T cell function. In addition, this platform is immediately applicable to studies
investigating additional immune agents, as well as cells central to other healthy and pathological physiologies.

Public health relevance
Public Health Relevance / Narrative Cellular response to changes in local tissue mechanics is emerging as a powerful regulator of both normal and pathological physiology including cancer. This project develops a platform for measuring and mapping the viscoelastic properties of tissues at scales important to the physiology of T cells, key agents of the adaptive immune response. Successful development of this system will lead to new mechanics-based strategies for improving T cell immunotherapy of solid tumors.